Identifying the Molecular Target of Two Novel Compounds Active Against Non-replicating Mycobacterium tuberculosis and Delineating the Role of the Putative Target, InhA, in Non-replicating States

Project Summary
Candidate and career development plan: Dr. Kohta Saito is an Infectious Diseases physician committed to
translational research in the fields of antimicrobial discovery and biology of non-replicating pathogens,
specifically Mycobacterium tuberculosis (Mtb). His overarching goal is to become an independent physician-
scientist pursuing questions of pathogen stress-response and antibiotic tolerance in order to discover novel
treatment methods. In the short term, his goals are: 1. To gain skills in the genetic manipulation of Mtb, 2. To
learn lipidomic techniques and apply them to the physiology of pathogen response to drugs and host stress, 3.
To hone expertise in the study of immune cell interaction with Mtb, 4. To transition to an independent investigator.
Environment: Weill Cornell Medicine (New York, NY) is well suited to develop Dr. Saito's career and already
equipped to accomplish the proposed research. A large infectious diseases division, tri-institutional resources,
and a collaborative TB Research Unit provide fertile ground for the appropriate training Dr. Saito will undertake.
Research: The proposed work extends Dr. Saito's experience with Mtb that become tolerant to antibiotics upon
exposure to stresses that cause entry into a non-replicative (NR) state. He will use two compounds that kill NR
mycobacteria and identify the NR target. Specifically, he will test whether InhA, a cell wall synthesizing enzyme,
is the relevant target. He will also test the essentiality of InhA in NR conditions without compound exposure.
Specific Aim 1. Identify the NR target of two novel compounds that kill NR mycobacteria. We hypothesize that
two compounds, AN1 and AN2, kill NR Mtb via direct inhibition of InhA. We will test this with 3 methods: 1.
Recombineering InhA mutations in Mtb and testing susceptibility to AN1 and AN2 in NR condtions, 2. creating
conditional knockdowns of InhA in Mtb and assessing their susceptibility to AN1 and AN2, and 3. comparing lipid
profiles of NR Mtb before and after compound exposure.
Specific Aim 2. Determine the essentiality of InhA in varied models of NR Mtb. We hypothesize that InhA is
essential to Mtb in NR states. We will create a conditional InhA knockout strain, and then assess its viability in
relevant stress conditions, including exposure to human macrophages, neutrophils, and serum. Metabolomic
and lipidomic changes that occur with knockdown strains in NR conditions will also be investigated.
Significance: The proposed work will define a process vital to survival of Mtb in NR states, and delineate the
role of InhA in NR states. This will advance the field's understanding of Mtb response to physiologic stresses,
and provide drug targets that promise to shorten tuberculosis therapy.

Public health relevance
Project Narrative Clinically, tuberculosis requires treatment for months with multiple drugs, and can enter a latent stage. Dr. Kohta Saito will study Mycobacterium tuberculosis (Mtb) in non-replicating states that make it tolerant to current therapy, and that may underlie these clinical barriers to efficient cure of tuberculosis. He will investigate the processes vital for Mtb survival in stress conditions through the action of novel compounds that can kill non- replicating Mtb, and this will prepare him for a career as an independent physician-scientist.